Reproductive Responses to the Zika Virus Epidemic in Brazil

PROJECT SUMMARY/ ABSTRACT
The objective of the proposed research is to provide one of the first in-depth analyses of how the Zika virus
(ZIKV) epidemic has affected and potentially continues to affect reproductive processes in Brazil. These
analyses will include investigations into how different types of physical and social exposure to the virus shape
women's desires for pregnancy and contraception, contraceptive use and sexual frequency, prenatal
healthcare use, abortion, and pregnancy and birth outcomes. Understanding women's reproductive responses
to ZIKV exposure is key to developing a nuanced understanding of the effects of population health shocks on
family health and health disparities more broadly, and is especially important to consider in a developing
country context where vast inequalities in healthcare access, unintended pregnancy, and morbidity and
mortality persist. Currently, little data or research is available on the secondary effects of the Zika epidemic on
reproductive health in Brazil. To address this gap the proposed study will collect new panel data among a
racially and socioeconomically diverse, population-representative sample of women of reproductive age from
two Brazilian states. These data will be collected twice—once every two years—and will feature a wide range
of measures of individual and municipal Zika exposure as well as measures of women's reproductive
intentions, behaviors, and outcomes; and a range of potential mediators such as risk perceptions, knowledge
about Zika, healthcare access, and psychosocial dimensions of fertility like contraceptive self-efficacy and
gender ideology. Repeated measurement among the sample will allow us to observe dynamic changes in
women's ideational and behavioral responses as medical science advances the prevention of Zika and/or Zika
reemerges as an epidemic in Brazil. To better understand the effects of Zika exposure at the community and
state level, we will merge our longitudinal survey data with municipal, state, and national administrative data
and climate data. In addition to these analyses, we will also examine administrative data on live births to
estimate fertility responses to the ZIKV epidemic. The specific aims of this project will be to: (1) collect
longitudinal data on physical and social ZIKV exposure, reproductive processes, and potential mediators; (2)
estimate the extent to which sociodemographic, municipal, and state characteristics affect women's physical
and social experiences of ZIKV exposure; and (3) investigate how and why reproductive intentions, behaviors,
and outcomes vary with ZIKV exposure. Multilevel fixed and random effects regressions, regression
discontinuities, and difference-in-difference models will be used to assess how different types and intensities of
ZIKV exposure influence women's reproductive strategies and to investigate the mechanisms underlying
reproductive responses to the epidemic.

Public health relevance
PROJECT NARRATIVE The proposed study will collect new panel data to investigate the effects of different types of physical and social exposure to the Zika virus on women’s reproductive intentions, behaviors, and outcomes in Brazil. The findings promise to advance research and theory on population health shocks by examining whether and how women adopt reproductive strategies aimed at mitigating perceived threats to fetal wellbeing while also highlighting the consequences of the recent epidemic for disparities in reproductive health. Findings from the proposed study will further inform policies and outreach strategies intended to reduce unmet need for contraception and unintended fertility, especially amidst major reproductive health crises.